Toward novel therapies against Lyme disease through the inhibition of lysinoalaine cross-linking in the bacterial flagella.

Treponema pallidum (Tp), Borrelia burgdorferi (Bb), Leptospira interrogans (Li) and Treponema denticola (Td)
are spirochete bacteria that cause syphilis, Lyme disease, leptospirosis, and are associated with periodontal
diseases in humans, respectively. These organisms cause substantial morbidity and mortality in the United
States and throughout the world. Owing to the prevalence of Lyme disease and emergence of antibiotic
resistance in Tp and Td, our long-term goal is to develop novel drugs that specifically treat diseases
caused by spirochetes.
Spirochetes are highly invasive bacteria, and their unique mode of motility plays an essential role in their ability
to penetrate and invade host tissues and organs. The flagella of spirochetes reside within the periplasm and are
thereby shielded from the immune system. A key component of bacterial flagella termed the hook joins the
flagella filament to the membrane-imbedded rotary motor. The hook consists of multiple FlgE proteins, and in
contrast to other bacterial flagella, spirochete FlgE proteins are covalently cross-linked to one another. This
cross-link involves formation of a novel lysinoalanine (Lal) amino acid. The central hypothesis is that the FlgE
proteins are covalently cross-linked to strengthen the hook for optimal motility and virulence. It is
proposed that understanding the structure of the cross-link, its chemical synthesis and its role in virulence will
lead to the development of drugs that inhibit cross-linking for treating spirochetal diseases.
Specific Aim 1. Investigate the effect of FlgE cross-linking on the infectivity of Bb. Mutants of Td and Bb
that are unable to cross-link their hook proteins are also altered in shape and deficient in translational motility.
To determine the importance of cross-linking for Bb virulence, we will produce a virulent strain impaired in FlgE
cross-linking and evaluate its ability to swim and sustain infections in both mice and ticks.
Specific Aim 2. Develop small molecule inhibitors of FlgE cross-linking. The chemistry of LA formation is
biologically unprecedented. Based on mechanistic and structural studies we have established cross-linking
assays with recombinant FlgE proteins from Td and Bb for large-scale inhibitor screens. With these assays we
have discovered an inhibitor of FlgE cross-linking and Bb motility. We will further characterize the action of this
compound and continue to identify and characterize additional classes of inhibitors to be used for studying
pathogenesis in hosts and eventually as lead compounds for therapeutics.
Specific Aim 3. Determine the effects of FlgE cross-linking on the structure and stability of the flagella
hook. To test whether the FlgE cross-links stabilize the hook to resist the high mechanical stress it likely
experiences in the periplasmic space, we will analyze the physical properties of cross-linked and non-cross-
linked hooks. In addition, the requirement of cross-linking will be tested by chemically restoring function in
absence of Lal.

Public health relevance
A group of bacteria called spirochetes cause syphilis, Lyme disease, leptospirosis, and are associated with periodontal diseases. The motility of these spiral- or flat waved shaped bacteria enable these micro-organisms to invade and damage host organs and tissues. Our long-term goal is to develop novel drugs that specifically target and inhibit this invasiveness for treating spirochetal diseases.